COBRE CORE D: DARTMOUSE SPEED CONGENICS CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Through SNP analysis of mouse genomes, DartMouse enables the rapid introgression of modified genes onto any inbred strain of mouse. Speed congenic strains of mice are achievable in 5 generations (1 to 1.5 years), versus 10 generations (~3 years) required by conventional back-crossing. The application of DartMouse services saves both money and time for researchers using the laboratory mouse for any number of pre-clinical disease models. DartMouse is a complete service facility that works closely with clients at and outside of Dartmouth, helping to design appropriate breeding schemes to optimize back-crossing speed and efficiency. Clients supply mouse tail-snips. DartMouse isolates genomic DNA, performs and analyzes complete genome-wide scans, and returns data in graphical and spreadsheet formats. DartMouse discusses results with clients and makes specific recommendations on breeder selection. DartMouse uses "SNP-Chip" technology on an Illumina BeadStation 500 Platform. Chips use a 377 SNP array covering the mouse genome with an average interval density of 7 cM. Turnaround time from receipt of tails to results is typically 2 weeks. A popular service is the "background check," in which the genetic backgrounds of mice can be thoroughly assessed across the genome.